Career Developmental Research Program

The Career Developmental Research Program exists to identify, support, and mentor candidates with promising independent careers in translational research. The Career Development Research Program also represents an opportunity to encourage new and established non-translational investigators, including women and minorities, to consider careers in translational research. In this manner the program ultimately serves as a means to expand translational research, as well as a source of translational projects and investigators for the SPORE Program itself.